Resolving Methodological Challenges in Genomics Research: Causality, Risk Prediction, and Reproducibility

Project Summary
With the rapid advances in high-throughput sequencing technology, genetic and genomic studies
have expanded significantly in scale and scope, enabling systematic surveys of large population
cohorts and a wide spectrum of clinical and molecular phenotypes. Yet, the scientific community
faces mounting challenges in translating data into meaningful insights for understanding disease
origins and supporting therapeutic development. Our proposed research targets three inter-
related methodological challenges in current genetics and genomics research: i) inference of
causal molecular mechanisms underlying complex diseases using observational genetic data and
genomic annotations; ii) improving risk prediction models using personalized genetic and genomic
information; iii) statistical assessment of reproducibility patterns in genomic data, driven by either
genuine biological heterogeneity or unwanted extraneous batch effects. We will develop
statistically rigorous and computationally efficient computational methods and open-source
software packages. Furthermore, we aim to advance computational techniques tailored for
analyzing complex and large-scale genomic data.

Public health relevance
Project Narrative This project will develop and apply computational tools to i) gain insights into the molecular mechanisms underlying complex diseases, ii) improve risk prediction using personalized genetic and genomic information, iii) perform rigorous reproducibility assessment in biomedical research. All three aspects are fundamental in complex disease studies, where the knowledge will eventually lead to new and reliable treatment strategies.